hHv1 channels in neutrophils and the innate immune inflammatory response

SUMMARY/ABSTRACT (30 lines)
Relevance to public health. Polymorphonuclear leukocytes (PMN, neutrophils) release reactive
oxygen species (ROS) to combat infection, but this inflammatory response can also initiate and propa-
gate lung damage. Acute lung injury (ALI) and its severe form, acute respiratory distress syndrome
(ARDS) that is fatal in 40% of patients, are characterized by accumulation of albumin-rich fluid in the
pulmonary air spaces. Drug therapies focused on downstream cytokine actions have failed to improve
morbidity or mortality; we hypothesize, and offer evidence, that targeting the human voltage-gated pro-
ton channel (hHv1) at early steps can be more effective. We propose to target hHv1 because (i) the chan-
nel in PMN initiates and sustains the inflammatory response, (ii) C6, a unique blocker of hHv1 sup-
presses human PMN ROS production, and (iii) C6 suppresses lung compromise in an ALI mouse model.
Brief background. This application builds on advances in the last period when we created the first
high-affinity and specific direct blocker of hHv1 (C6 peptide) and used it to show, first, that human
sperm require hHv1-mediated H+ efflux to initiate capacitation, allowing the acrosomal reaction, and
oocyte fertilization and, second, that hHv1 in human PMN is required to produce and sustain release of
inflammatory agents, including ROS and proteases, during the innate immune inflammatory response.
Unique features and innovation. Our pilot data reveal a second target in the pathway: albumin
(Alb) is required to activate hHv1 in human PMN and we describe a peptide (L*) that blocks Alb-activa-
tion and ROS production. Supporting our driving hypothesis, we show here that both C6 and L* inhibit
hHv1 in human PMN, decreasing ROS production, and that C6 protects in an ALI mouse model, restor-
ing lung compliance, and decreasing ROS, proinflammatory cytokines, protein, and PMN in bron-
choalveolar lavage fluid. We employ our novel membrane tethered (T-peptide) method to speed struc-
ture-function studies and peptide design, show a bivalent C6 (C62) that fully inhibits open hHv1 chan-
nels, benefit from advanced biophysical and in vivo methods, and two expert collaborators.
Three specific aims. (1) Alb activation of hHv1 seeks the structural and mechanistic basis for the
action of Alb and a more potent natural metabolite. (2) Alb regulation of the PMN inflammatory re-
sponse seeks to delineate the role of hHv1 in PMN using C6, C62 and L* and the basis for peptide action.
(3) Inhibiting acute lung injury with Hv1 inhibitors studies an ALI model in WT and Hv1 KO mice.
Significance. This work addresses an unmet medical need, recently made more apparent by the ad-
vent of COVID-19-related ALI/ARDS and has broader influence because Hv1 in PMN and other phago-
cytes is complicit in additional acute and chronic inflammatory disorders. We propose to apply unique
hHv1 inhibitors and innovative methods to understand and suppress this pathophysiology.

Public health relevance
NARRATIVE (General Audience, public health relevance, 2-3 sentences) This research addresses a specific unmet medical need, the absence of an effective medical therapy for acute lung injury (ALI), a common disorder in patients with bacterial pneumonia or SARS-CoV-2 infec- tion and its severe form, acute respiratory distress syndrome (ARDS) that is fatal in 40% of patients. The work is broadly impactful because the white blood cells called neutrophils (Polymorphonuclear leuko- cytes, PMN) that damage the lungs in infectious ALI/ARDS also cause other acute and chronic inflam- matory diseases. In the last period, we showed that the human voltage-gated proton channel (hHv1) in PMN is essential to produce the inflammatory response, and we propose here to confront lung injury by a novel strategy: targeting hHv1 in PMN, both directly and by blocking a natural activator of hHv1, al- bumin (Alb), that we recently reported to be required for hHv1 operation, thereby offering two ways to confront the disease at the earliest stage before it becomes a more complex disorder.